Machine Learning-Based Identification of Cardiomyopathy Risk in Childhood Cancer Survivors

PROJECT SUMMARY / ABSTRACT
Treatment-related cardiomyopathy/heart failure (CHF) is a leading cause of premature morbidity in childhood
cancer survivors. Given the widespread use of anthracycline and related cardiotoxic chemotherapeutics, and in
combination with radiotherapy exposure to the chest, over half of long-term survivors of childhood cancer are at
significantly increased risk of early CHF compared with an age-matched general population. Currently, national
and international consensus guidelines recommend the routine use of 2-dimensional (2D) echocardiography to
screen this high-risk population for early signs of CHF, in particular, left ventricular (LV) systolic dysfunction and
changes in LV geometry. At present, 2D echocardiography represents the standard of care across the US given
its widespread availability, relatively lower cost, and avoidance of ionizing radiation or sedation. Nevertheless,
limitations of 2D echocardiography include greater intra-patient and inter-observer variability. As a result, current
echocardiography-based surveillance continues to have limited sensitivity and often requires serial studies
before a patient is identified as having a potential abnormality. Although there is insufficient evidence to guide
CHF management specific to pediatric cancer survivors, the evidence for non-cancer-related cardiomyopathy in
both children and adults suggests that earlier intervention can mitigate or delay CHF progression. Therefore,
methods that improve the detection of early CHF in childhood cancer survivors may have important clinical
implications. Deep learning (DL), a subfield of machine learning, can automatically extract patterns from large
unstructured datasets, such as medical images, and is increasingly being utilized in medicine for disease
diagnosis as well as disease onset and outcome prediction. We propose to leverage a unique imaging dataset
we have assembled from the Children’s Oncology Group (COG), a part of the NCI-sponsored National Clinical
Trials Network and Community Oncology Research Program, to explore the potential of DL for enhanced
detection of CHF. We have longitudinal echocardiographic data on over 100 survivors of childhood cancer who
developed CHF and over 350 who did not, all defined using standardized criteria, representing an imaging
repository of >3000 individual echocardiograms (and growing). Using this extant and clinically annotated dataset,
we propose to: 1) Using a deep convolutional neural network (DCNN), identify the optimal process for a DL-
based assessment of CHF in pediatric cancer survivors; and 2) Assess the feasibility and preliminary efficacy of
DCNN-based prediction of cardiomyopathy onset from pre-CHF diagnosis echocardiograms. Expected results
include the development of a DCNN that will differentiate between abnormal and normal echocardiograms from
pediatric cancer survivors with and without CHF, respectively. After optimization, we will conduct a preliminary
efficacy analysis to determine how many years in advance a survivor's transition to CHF can be predicted using
an optimized DCNN.

Public health relevance
PROJECT NARRATIVE Childhood cancer patients have an increased risk of developing heart failure because of chemotherapy and radiation treatments. As a result, many survivors of childhood cancer receive lifetime screening with echocardiograms (ultrasound of the heart) to monitor their long-term heart function. The proposed project would apply new computer artificial intelligence-based methods to improve the ability of echocardiograms to detect earlier heart disease in these high-risk survivors.